Role of Intracortical Mechanisms Vs. Bottom-Up Influences in Developmental Desynchronization of Cortical Network Activity

ABSTRACT
Studying how cortical circuits mature is critical to understanding neurodevelopmental conditions as proper wiring
of these circuits is important for perception and cognition. Initially, spontaneous neuronal activity in the
developing neocortex is characterized by intermittent, brief bursts of synchronous network events that interrupt
much longer periods of no activity. Network activity then undergoes a transition from network-wide synchronous
events to the asynchronous, sparse neuronal firing seen in adults. This desynchronization of network activity is
a robust phenomenon that is conserved across many species, including in humans; in mice, it occurs during the
second postnatal week. Because sparse firing is conducive to greater computational coding power,
desynchronization is a crucial step in neurodevelopment. However, the mechanisms driving cortical
desynchronization are unknown. Understanding these mechanisms would provide insight into the
maturation of neural circuits and, critically, into the origin of neurodevelopmental conditions (NDCs),
such as autism, epilepsy, and intellectual disability. Indeed, cortical network synchrony during development
is persistently elevated in some mouse models of NDCs, suggesting that the trajectory of desynchronization is
different in those NDCs. There are two principal mechanisms that could underlie cortical desynchronization: 1)
intracortical mechanisms, and 2) bottom-up mechanisms. Intracortical mechanisms, such as an increase in
inhibition or a decrease in intrinsic neuronal excitability, could shift the network away from the runaway excitation
needed to generate synchronous events. Alternatively, bottom-up mechanisms could directly drive cortical
desynchronization via changes in the activity of upstream brain regions like the thalamus. This proposal will
compare the primary somatosensory cortex (S1), which receives dense bottom-up input from the periphery via
thalamic relay nuclei, to the secondary motor cortex (M2), a nearby cortical region that receives little direct input
from the periphery, to elucidate the contributions of intracortical vs. bottom-up mechanisms. Specific aim 1 will
test whether inhibition drives cortical desynchronization in S1 and in M2 by utilizing in vivo longitudinal 2-photon
calcium imaging from postnatal days (P) 9 to 14 to assess how the trajectory of desynchronization changes when
local inhibitory interneurons are chronically inhibited with chemogenetics during the desynchronization window.
Specific aim 2 will determine the role of bottom-up mechanisms by testing whether disrupting synchronous
thalamic activity can alter the trajectory of cortical desynchronization in S1 and in M2. Specific aim 3 will
characterize the specific genetic changes occurring in S1 vs. M2 during desynchronization using single-nucleus
RNA sequencing. Together, these aims will provide insight into how cortical circuits mature. Crucially, this
proposal will investigate different regions of cortex—with vastly different inputs—to disambiguate the contribution
of intracortical vs. bottom-up mechanisms in driving cortical desynchronization.

Public health relevance
PROJECT NARRATIVE Spontaneous neuronal activity in the developing cerebral cortex undergoes a crucial transition from intermittent network-wide synchronous events to the computationally more efficient, asynchronous, sparse neuronal firing of adults. However, the mechanisms underlying this major developmental transition in brain activity are unknown. This proposal will investigate the contribution of intracortical vs. bottom-up mechanisms in driving desynchronization to provide fundamental insight into how neural circuits mature and how this process may be different in neurodevelopmental conditions such as autism.